The non-catalytic function of PARP2 in DNA repair and cancer therapy

PROJECT SUMMARY/ABSTRACT
PARP1 and PARP2 are DNA damage-induced poly-ADP-ribose (PAR) transferases, which are recruited
to and activated by DNA breaks. Active PARP1&2 PARylate themselves and histones to promote DNA repair
and chromatin relaxation. Dual-specificity inhibitors (PARPi) for PARP1 and PARP2 are currently used for the
treatment of BRCA1/2-deficient breast, ovarian, pancreatic, and prostate cancers. However, severe anemia
occurs in ~ one-third of patients, leading to dose reduction and premature termination of PAPRi therapy. PARPi
also cause significant clonal hematopoiesis, a condition that increases the risk for myeloid dysplasia and acute-
myeloid leukemia (MDS/AML). These hematopoietic toxicities are unexpected since the complete loss of Parp1
that is responsible for >80% of DNA damage-induced PARylation in cells, has no impact on hematopoiesis. To
understand this potential on-target toxicity of PARPi, we generated mouse models with knockin catalytically
inactive mutations in Parp2 – Poly-ADP-Ribosylation (PARylation) deficient (E534A, Parp2EA) or Mono-ADP-
Ribosylation (MARylation) deficient (H404A, Parp2HA). In contrast to the normal development of Parp2-/- mice,
mice expressing PARylation deficient PARP2 (Parp2EA/EA) died at embryonic day 16.5 (E16.5) with severe
anemia and stage-specific blocks in erythropoiesis. The Parp2HA/HA mice are viable but display splenomegaly
and chronic anemia. Meanwhile, our cell biology analyses suggest that clinically used PARPi effectively stalls
PARP2, but not PARP1, on laser-induced DNA damage sites. Based on these and other observations, we
hypothesize that PARP2 has PARylation-dependent structural functions that preferentially block nick
ligation during DNA replication, underlie the PARP inhibitors-induced erythropoiesis defects and anemia.
Specifically, we propose that catalytically inactive PARP2 were trapped on DNA breaks, especially 5’pho-nicks,
where they prevent other repair factors (e.g., Ligase1) from accessing the DNA nicks. Correspondingly, like the
Parp2EA/EA mice, Lig1-/- mice also succumbed to lethal anemia at E16.5. To test our hypothesis, we will Aim 1)
investigate the mechanism that regulates PARP2 recruitment and dynamics at DNA damage sites using live-cell
imaging and bulk biochemical assays; Aim 2) determine the impacts of catalytically inactive PARP2 on the
recruitment and function of other DNA repair factors, and DNA replication in vivo and in vitro; Aim 3) characterize
the mouse models expressing catalytically inactive - Parp2 and investigate how the loss of Trp53, CHK2, two
genes associated clonal hematopoiesis, modulates the anemia in Parp2EA/EA models. The completion of the
proposal will characterize the previously unrecognized structural functions of PARP2, address how catalytically
inactive PARP2 compromises DNA replication and selectively abrogates erythropoiesis, providing the strategy
to mitigate this on-targeted toxicity of PARP inhibitors by reducing PARP2 stalling.

Public health relevance
PROJECT NARRATIVE Our proposal utilizes mouse genetic, live-cell imaging, flow cytometry, biochemistry, and molecular biology approach to identify 1) the mechanism that regulates the recruitment and disassociation of PARP2 from the DNA damage sites, 2) the impact of trapped PARP2 on DNA repair and DNA replication, 3) the effects of PARylation/MARylation defective PARP2 on erythropoiesis, hematopoiesis, Trp53/CHK2 mediated clonal expansion. The ultimate goal is to understand the newly identify structural role of PARP2 in hematopoiesis and cancer therapy and to mitigate the on-target bone marrow toxicities of clinical PARP inhibitors.